Stanford Diabetes Research Center

CENTER OVERVIEW: PROJECT SUMMARY/ABSTRACT
The Stanford Diabetes Research Center (SDRC) embodies the culmination of a strategic plan by the Stanford
University School of Medicine to create a premier program founded on a base of superb, collaborative
investigators studying basic, clinical and translational problems in diabetes research. The SDRC mission is to
foster innovation, new knowledge, and training in diabetes-related research, leading to improved diagnosis,
treatment, and ultimately, prevention and cure of diabetes and its complications. Renewal of this P30
application will leverage diabetes research at Stanford University by providing crucial resources dedicated to
supporting investigations and enrichment activities focused on diabetes. Stanford has a strong tradition of
academic excellence, innovation, and clinical care, united in a true University on a single campus that fosters
interactions between scientists and clinicians from different disciplines. Stanford is in the heart of Silicon
Valley, an epicenter of innovation and calculated risk-taking, whose companies partner with SDRC faculty in
unique and growing collaborations to advance diabetes research and care. Stanford neighbors two Universities
of California (UC) at Berkeley, and at Davis, both elite research centers with a growing diabetes research base
unconnected to a NIDDK DRC. The SDRC is comprised of 124 members from 3 Schools at Stanford, and from
multiple Schools at UC Berkeley and UC Davis. SDRC members at Stanford currently have $65,044,250 in
annual direct costs for diabetes-related research. SDRC members are organized by affinity groups focused on
(i) Islet & Pancreas Biology, (ii) Metabolism & Signaling, (iii) Immunology, Transplantation & Stem Cell Biology,
and (iv) Bioengineering & Behavioral Sciences. The SDRC consists of: (1) Administrative Component that
coordinates scientific, organizational, enrichment, training and outreach activities, (2) Biomedical Research
Component that recruits and selects members, and supervises 4 Research Cores that facilitate and enhance
their research, and (3) a successful SDRC Pilot and Feasibility (P&F) Award Program that promotes the
diabetes research of early stage investigators, and established scientists new to diabetes research. We
propose to expand this Program to include a Regional P&F Program that supports research at UC Davis and
Berkeley. NIH support for the SDRC is amplified by (1) Stanford’s sustained commitment to provide space and
significant financial resources, (2) a comprehensive array of institutional research cores, which allow NIDDK
funds to support specialized SDRC research cores devoted to diabetes research, (3) collaborative efforts with
other Stanford research centers, and (4) SDRC member leadership of high-profile national diabetes research
efforts. Since P30 funding began in 2017, the SDRC has evolved, including growth of its investigator base,
intensified focus on translational research, and modification of core services to provide indispensable support
for diabetes research. By multiple metrics, the SDRC is a force multiplier of innovation, whose members make
seminal scientific contributions related to basic and translational diabetes, obesity, and metabolism research.

Public health relevance
CENTER OVERVIEW: PROJECT NARRATIVE This P30 renewal application from the Stanford Diabetes Research Center (SDRC) seeks support for its efforts to discover, apply and translate science about diabetes and it complications, with the goal of improving health by reducing the burden of diabetes. The SDRC was founded on a base of superb, collaborative investigators studying basic, clinical and translational problems in diabetes at Stanford University, which has a tradition and reputation for scientific innovation and clinical care, located in the heart of Silicon Valley, an epicenter of transformative discovery and calculated risk-taking. Renewal of this P30 application will leverage diabetes research at Stanford University by providing key resources to support Research Cores, maintain a highly successful SDRC Pilot and Feasibility Award Program, creation of a Regional Pilot and Feasibility Award program to foster innovative diabetes research at the University of California (UC) Berkeley and UC Davis, and Enrichment Programs focused on diabetes research, education and care.